Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD)

ABSTRACT (Overall)
This is a competing renewal application for the Environmental Health Sciences Core Center at the University of
Michigan, submitted in the final year of our second term of support. Our Center is organized around the theme
of critical windows of susceptibility to environmental exposures as important determinants of disease, forming
the Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD). Lifestage, as used in this
application, refers to clinically-recognized stages of development, mid-life, and aging that pertain to the pre-
conception, prenatal, infant, child, adolescent, reproductive age adult, and aging adult periods. Our Center
builds on a strong foundation of research activity and support in environmental health sciences, with 22 NIEHS
grants and projects, including Outstanding New Environmental Health Scientist (ONES) and Revolutionizing
Innovative, Visionary Environmental health Research (RIVER) awards and participation in Superfund and other
NIEHS programs. The M-LEEaD mission is to accelerate research that defines impacts of environmental
exposures during vulnerable life stages and to promote translation of findings to improve clinical and public
health interventions for the mitigation of disease. Our Center implements its mission through infrastructural
support of established and new investigators applying novel transdisciplinary approaches that increase
understanding of how exposures target vulnerable stages of life. Support for research is provided through
integrated Center programs that include a Pilot Project Program, three Facility Cores, and three Research
Teams to enhance translation of research findings into applications for patients and communities to support a
comprehensive and integrated environmental health paradigm. Facility Cores are: Integrated Health Sciences
(IHS); Exposure Assessment (EA); and Pan-Omics and Data Science (PODS). Research Teams are organized
around translational impact: Cumulative Exposures & Population Health; Climate Change & Health Disparities;
and Toxicological Mechanisms & Health Outcomes. Research is coupled with engagement of stakeholder
communities through the Community Engagement Core (CEC), and training of future leaders through our
Career Development Program. An Administrative Core oversees the functioning of the Center. M-LEEaD
strives to accomplish its mission through four specific aims: 1) Integrate institutional programs and facilities to
provide structure and resources that accelerate understanding of complex relationships among environmental
exposures, human biology, and disease; 2) Foster integration and cooperation among investigators across
traditional and emerging disciplines to conduct research that translates to improved strategies to prevent
environmentally-induced disorders; 3) Build programmatic and scientific capacity through support for scientists
at critical career stages to engage in research that addresses critical questions in environmental health; and 4)
Engage with affected communities via equitable partnerships in a multidirectional manner to identify community
environmental health concerns and collaboratively translate research findings into action to promote health.

Public health relevance
Narrative (Overall) The Michigan Lifestage Environmental Exposures and Disease (M-LEEaD) Environmental Health Sciences Core Center provides infrastructural support for research, research translation, career development and training, and community engagement to address critical knowledge gaps of lifestage vulnerability to environmental exposures.